PAD4 in Retinal Gliosis

Abstract: Alzheimer disease (AD) and age-­?related macular degeneration (AMD) are two highly debilitating neurological diseases in which the mis-­?regulation of biological mechanisms in the aging central nervous system (CNS) leads to expression of certain common disease biomarkers. Citrullination, an irreversible post-­?translational protein modification catalyzed by the peptidyl arginine deiminases (PADs) has been linked to pathogenesis in both AD and AMD patients; however, the effort for linking citrullinated retinal targets as biomarkers of AD is not yet established. We recently discovered that early after retinal injury, protein citrullination increases in Muller cells and, in particular, the citrullination of the glial fibrillary acidic protein (GFAP) was associated with pathological gliosis. In orior studies we showed that inhibition of retinal citrullination potently abrogated expression of citrullinated GFAP isoforms (Mol Vis. 2016 22:1137-­?1155), the identification of PAD4 as the inflammation-­?inducible PAD enzyme has been key, because it illuminated a novel biomarker and potential druggable target of retinal gliosis (Biochem Biophys Res Commun. 2017 487:134-­?139). In pursuing the aims of our R21 grant, we have begun investigating PAD4 expression characteristics in the laser-­?injury model of wet-­?AMD. In new and exciting preliminary findings, we show that PAD4 expression increases in retinal Muller glia in the laser-­?injured retina showing localization on GFAP-­?containing filaments. Given the premise that PAD4 and citrullinated proteins are increased in human AD brains, we want to ascertain whether this citrullination axis is also activated in the retinas of AD models. For this supplementary grant proposal, we will investigate PAD4 and citrullinated targets in the retinas of established mouse models of AD (3XTg-­?AD, Reticulon3 overexpressor, and APP-­?PS1 transgenic lines). These studies will help define earliest time points in AD progression when citrullination becomes apparent. This ground-­?breaking study will laydown the framework for future studies to identify and validate novel retinal biomarkers of AD. In addition, we also hope to bring insight into how citrullination leads to neurodegeneration. Ultimately, identification of new retinal biomarkers of AD could afford a clinically relevant means for diagnostics and for monitoring AD therapeutic efficacy through non-­?invasive retinal imaging.

Public health relevance
Narrative This investigation focuses on identifying new biomarkers expressed in the retina of Alzheimer’s disease mouse models.